SORL1 and its involvement in Alzheimer's disease pathogenesis and pathophysiology - Core C: Human Induced Pluripotent Stem Cell (hiPSC)

CORE C SUMMARY
As discussed in the Overview, the overall goal of this PPG is to understand the pathogenicity and
pathophysiology of disease-associated variants in the Alzheimer's disease gene SORL1. AD is a major leading
cause of death in the developed world and there are currently no preventative or significantly disease-modifying
treatments. SORL1 is emerging as only the 4th gene that is considered causal in Alzheimer's disease, and new
insight shows how the SORL1 protein interacts with the retromer trafficking complex in mediating the disease's
cardinal pathologies. The overall approach in the PPG is to study a unified set of SORL1 variants that are
predicted to be pathogenic based on a recently developed prioritization framework (see Overview). The overall
PPG consists of four Cores and four Projects that together will pursue hypothesis-based experiments to test how
SORL1 variants affect retromer-dependent endosomal recycling as well as unbiased approaches to explore and
expand the mechanistic understanding of how SORL1 drives and/or modulates AD pathogenesis.
Core C will support the overall Program Project by generating and characterizing isogenic human
induced pluripotent stem cell (hiPSC) lines that harbor 22 selected SORL1 pathogenic variants. We will deliver
a comprehensive phenotypic analysis of these variants in hiPSC-derived neurons, astrocytes and microglia. Aim
1 will focus on neuronal phenotypes and include conventional AD read-outs such as A, phospho-Tau and early
endosome size. We will also examine novel phenotypes including secretion of Amyloid Precursor-Like Protein 1
(APLP1) secretion, soluble SORL1 (sSORL1) shedding, and cell surface localization of the glutamate receptor
subunit, GLUA1. Aim 2 will focus on glial phenotypes. Recent data from our laboratory suggests that SORL1-
retromer deficiency may converge on the lysosome in glial cells. We will measure lysosome size and function as
well as neuroimmune phenotypes, including phagocytosis and cytokine secretion, and glial functions such as
glutamate uptake. Aim 3 will use bulk RNA-sequencing of neuronal and glial cells harboring the different
pathogenic variants to identify new mechanistic pathways in an unbiased manner. Core C is well integrated into
the overall PPG. We will build upon the biochemical, cell biological, genetic and structural data in Projects 1
and 2 and Cores B and D. The data generated by Core C will inform and complement the mouse models
proposed in Project 3 and the biofluidic analyses proposed in Project 4. Together our Core, along with the other
Projects and Cores of the PPG, will provide a comprehensive overview of pathogenic SORL1 variants and
SORL1-retromer biology in human neurons and glia.